TREX:Texas Research Experience Experiment

PROJECT SUMMARY/ABSTRACT
The overall goal of the Texas Research Experience eXperiment (TREX) project is to create a sustainable
model for culturally relevant STEM learning environments that engage students' interests and prepare them for
careers in medicine, science, engineering, and technology. To this end, TREX will enhance training of high
school educators and students through a coordinated set of programs and activities that will build an enduring
mentoring “triad.” The triad will include (1) Texas A&M University (TAMU) faculty and trainees in the Schools of
Medicine and Public Health, and Colleges Education and Engineering, and (2) administrators, educators, and
students at a science magnet high school, and (3) a traditional public high school in south Texas. These
longitudinal mentoring relationships within the triad will promote sharing of resources and best practices,
facilitate the development of exportable, career centered, curricular modules, and provide enhanced
professional development for teachers and focused career development for students. Integrated
components that will provide longitudinal mentoring and career preparation include two-semester remote
TAMU faculty mentorship of high school teachers and students linked with on-campus TAMU summer
research internships for students. TREX focuses on school districts that are rural and have a high proportion
of students who are underserved and underrepresented in science and medicine. The multi-disciplinary
Project team, which includes experts in biomedical, health disparities, public health, and biomedical
engineering research, as well as educational theory, curriculum development, and evaluation, will work with
classroom teachers to develop innovative, career based, educational modules focused on 21st century
skills. Specifically, TREX aims (1) to provide high school teachers longitudinal mentorship to promote the
development of STEM instructional modules leading to an accredited, two-semester course for high school
juniors and seniors that includes journal clubs, hands-on experiments, and a seminar series to enhance STEM
foundation knowledge open to teachers, students, and community members; and (2) to provide rigorous,
mentored instruction for high school students on scientific inquiry fundamentals (semester 1) and authentic
research experiences (semester 2) through the creation of capstone projects that can be further actualized in
the laboratories of the TAMU faculty mentors during summer research internships.
All activities and products will be extensively evaluated using a quasi-experimental, mixed methods
approach, with a variety of instruments designed to collect and analyze the most pertinent data. These will
assess the effectiveness of the model in achieving the objectives of enhancing student interest and
developing the skills needed for educational and career success. The curriculum and framework developed
as part of TREX will be made publicly available to high schools and universities to encourage high school
research collaborations that spark similar programs.

Public health relevance
PROJECT NARRATIVE The Texas Research Experience eXperiment (TREX) project will establish partnerships for the development of high school curricular modules and career development activities designed to stimulate interest in and preparation for careers in science, technology, engineering, and medicine through longitudinal mentoring of teachers and students by university faculty and summer research internships for students in faculty laboratories. The project is focused on rural school districts that are in medically underserved communities and have high proportions of students who are of low socioeconomic status and underrepresented in science and medicine.